Integrative spinal physiology to restore neural control of sensorimotor functions after neurological injury

Project Summary/Abstract
Spinal cord injury (SCI) often results in reduced voluntary motor output, neuropathic pain, and autonomic
dysfunction. Unfortunately, pre-clinical research and clinically available therapies alike have failed to adequately
address the complex interrelationships amongst these changes in neural activity, despite widespread recognition
that inappropriate neural transmission in overlapping spinal networks underpins them all. This mechanistic
overlap suggests both that therapies intended to enhance recovery in one domain will likely impact multiple
domains simultaneously and that it may be possible to leverage the dense interconnectivity of spinal networks
to purposefully engineer multi-modal rehabilitation therapies – i.e., those specifically intended to address more
than one consequence of SCI. The ultimate goal of this work is to enhance quality of life for people living with
SCI by developing multi-modal therapies grounded in an integrative, neuro-mechanistic understanding of spinal
cord function. Aim 1 (F99 Phase) will focus on neurotechnology-driven multi-modal therapies to simultaneously
increase voluntary motor output while ameliorating neuropathic pain in a clinically relevant rat model of SCI. To
do so, I will study potential contributions of neurons in the motor-dominant regions of the spinal gray matter to
the spinal nociceptive process overall, which is traditionally only studied and characterized in the sensory-
dominant regions of the spinal gray matter. We will test whether a latent pain-processing network is present in
motor-dominant regions of the spinal gray matter, which becomes unmasked during periods of nociceptive
transmission in rats with SCI. We predict that the emergence of this previously undetected network will be
increasingly evident in rats with SCI-related neuropathic pain. If identified, this network could provide a new
target for neuroprosthetic therapies to deliver multimodal rehabilitation benefits. This would address two critical
unmet needs of the SCI population: non-opioid treatments for SCI-related neuropathic pain and multimodal
rehabilitation. Aim 2 (K00 Phase) will focus on enhancing multi-modal rehabilitation intended to simultaneously
improve bladder, bowel, and sexual dysfunction after SCI (i.e., pelvic floor dysfunction). Restoration of functions
compromised by inappropriate neural control of pelvic floor muscles is a top rehabilitation priority for people living
with SCI. Yet, despite its impact on physical and psychological health, the neural control of pelvic floor muscles
is a comparatively understudied area of spinal physiology and neurorehabilitation. Thus, in the K00 Phase I will
study the spinal neural control of pelvic floor muscles through the lends of somatic and autonomic integration,
which is both essential for maintaining appropriate pelvic floor function and is disrupted by nearly every SCI. I
will then be prepared to establish an independent research line developing multi-modal therapies that address
the intersectional challenges faced by people living with SCI-related bowel, bladder, and sexual dysfunction.

Public health relevance
Project Narrative / Public Health Statement Spinal cord injury results in debilitating motor deficits, neuropathic pain, autonomic dysfunction, bladder, bowel, and sexual dysfunction. The objective of this proposal is to inform the design of multi-modal rehabilitation therapies – i.e., those specifically intended to restore multiple functions simultaneously. If successful, this work could lead to a new, more efficacious therapies for individuals living with spinal cord injury.